CANCER CENTER CORE SUPPORT GRANT

The University of Arizona has established a Cancer Center based in the College of Medicine. The goals of the Center are to: 1) become a major geographic resource which will add direction and focus in the national network of cancer centers; 2) promote excellence in clinical and laboratory cancer research, patient care, and education; 3) develop an "outreach program" to serve the State of Arizona and the Southwest.